X-ray/optical tomographic guidance and assessment for pre-clinical radiation Research

PROJECT SUMMARY/ABSTRACT
Over the past 10 years, our group has made multi-disciplinary efforts to bridge the technological gap between
radiation methods for human treatment and pre-clinical research. We employed the Bioengineering Research
Partnership mechanism to construct an advanced small animal radiation research platform (SARRP). The
SARRP is equipped with cone-beam CT (CBCT) to guide focal irradiation and was commercialized by Xstrahl
in 2010. The system was transformative for pre-clinical radiation research as 66 machines are now in use
world-wide by > 300 investigators. Recognizing that CBCT imaging is inadequate for localizing tumor models
growing in a low image contrast environment, we developed bioluminescence tomography (BLT) on board the
SARRP to complement CBCT guidance. The effort was supported by the previous academic-industrial
partnership (AIP) mechanism. The BLT utility is the “first” to localize the center of mass (CoM) of an optical
target for irradiation. Although the success of this partnership led to the commercialization of the BLT system
by Xstrahl in 2016, the adoption of the BLT platform by users is lackluster. It is clear that investigators highly
desire the ability to define the 3D shape of the target volume on the SARRP to fully complement modern
human treatment. It becomes imperative that we need to advance BLT guidance to a new level of 3D target
shape delineation beyond CoM and to allow quantitative assessment of target response to radiation. On-board
PET imaging has been introduced to enable biology-guided RT in humans. Small animal radiation research
would also be greatly enhanced with capabilities of biologic and functional targeting and assessment beyond
anatomy. Fluorescence tomography (FT) would allow in-depth biological and mechanistic interrogation of key
information about the tumor and its microenvironment response to RT. It complements bioluminescence
imaging to study tumor and normal tissue response, when the use of engineered bioluminescent models is not
available. The research potentials of FT are particularly significant when considering combinational molecular
therapeutic strategies with radiation, such as immunotherapy. Fluorescence imaging also has an added
advantage to be amenable to clinical translation as a surrogate for PET imaging. Integrated CBCT/BLT/FT
capabilities that complements the SARRP would provide a powerful platform for pre-clinical radiation research.
Xstrahl and the Johns Hopkins team will continue the partnership to develop and commercialize these new
capabilities. Our aims are (1). Design and construct a new advanced BLT/FT system to guide irradiation on-
board the SARRP and for off-line imaging studies, (2). Develop quantitative BLT/FT for target volume
determination and treatment assessment, (3). Assess and validate the optical system performance with
phantom and in vivo model. The successful dissemination of new advanced molecular optical imaging
capabilities significantly enhances the conduct of radiation research for the SARRP users.

Public health relevance
PROJECT NARRATIVE We propose to significantly advance the in vivo cancer imaging capability of our small animal radiation research platform (SARRP) to include quantitative bioluminescence and fluorescence tomography. The novel optical imaging system is expected to enhance pre-clinical radiation guidance and assessment for anatomical and functional targets. The dissemination of the functional imaging SARRP platform is particularly important at the present time when radiation is being tested not only for its efficacy as a local control agent but also as an effective modulator for immunotherapy and other biologic therapeutics.